Skin Translational Research

PROJECT SUMMARY
The Skin Translational Research (STaR) Core aims to foster innovative and pathophysiologically relevant skin
biology and disease research by facilitating experiments using human primary samples. Fresh human skin and
primary skin cells are highly valuable resources that help to extend skin research throughout the larger
scientific community at our institution, evidenced by the large number of investigators outside the Department
of Dermatology who have previously used our Core services and subsequently submitted new abstracts,
publications, and grant applications on skin biology. By combining highly utilized primary tissue services with
innovative tissue engineering, high-throughput screening, and biobanking consultation and services, STaR
Core aims to maximize our impact within an even broader scientific community. Our long-term objectives are
to: (1) allow investigators both within and outside the Department of Dermatology to conduct research on skin
biology more efficiently and effectively by centralizing high-volume or specialized technical services and
providing the critical research infrastructure and institutional review board approvals for their use; (2) foster
innovative exploratory projects and junior investigators in skin biology through our core services, with the goal
of promoting new scientific collaborations, abstracts, manuscripts, and grants; (3) promote translational
research by providing access to normal and diseased human skin samples that might not otherwise be
available to non-physicians or have substantial administrative barriers to their use; and (4) integrate our core
directors’ research expertise into future core services to adapt to the emerging needs and opportunities of our
membership. To accomplish these goals we aim to: 1) Accelerate novel pathway discovery through both
targeted investigations of candidate pathways as well as unbiased high-throughput screening assays in
primary human skin cells; 2) Enable 3-dimensional skin biology and disease modeling through ex vivo human
skin cultures, organotypic skin cultures, and human skin xenografts; and 3) Promote research using well-
annotated skin biospecimens by establishing the Penn Dermatology BioBank, which includes both normal and
diseased human skin samples, with or without paired blood samples, including linked clinical and genetic data.